Vestibulopathy, imbalance and gait disturbances in Parkinson disease

The management of dopamine resistant postural instability and gait difficulty (PIGD) features, such as freezing
of gait (FoG), represents perhaps the most important unmet clinical need in Parkinson's disease (PD).
Research into the role of the vestibular system in the etiology of FoG has largely been neglected. Age-
associated vestibular impairment (presbyvestibulopathy, PVP) is present in about half of older community-
dwelling older persons and is a significant contributor to imbalance and falls. PVP is also common in PD, an
age-related neurodegenerative disorder. We have novel preliminary data showing that PVP may be an
important factor contributing to FoG. Confirmation of a mechanistic link between vestibular dysfunction and
FoG has high clinical translational impact and may augur novel vestibular rehabilitation interventions, such as
in-home portable thermoneuromodulation (TNM) to treat PD Veterans with otherwise treatment-refractory FoG.
Plan: Our main aim will be a cross-sectional study in 64 Veterans with PD to investigate the relationship
between PVP and FoG. Our exploratory aim will be a mechanistic feasibility trial of portable TNM in PD
Veterans with FoG and PVP.
Methods: We will perform detailed clinical, including dedicated motor and vestibular testing. PE2I dopamine
transporter (DAT) PET will be used to assess the integrity of dopaminergic nigrostriatal innervation.
Hypothesis 1: The prevalence of FoG is higher in Veterans with PD who also have evidence of PVP
compared to those without PVP independent of nigrostriatal dopaminergic losses.
Exploratory hypothesis: Active TNM stimulation will result in improved FoG severity ratings compared to
sham stimulation in PD Veterans with FoG and PVP.

Public health relevance
The primary focus area of the project program addresses a clinical unmet need in the management of dopamine medication-refractory balance and gait problems, in particular freezing of gait, in Veterans with Parkinson disease (PD). The second focus area of the project addresses a critical gap in our understanding of how age-associated vestibular changes may affect motor freezing behaviors. The relevance of the project is that it tests a mechanistic hypothesis that age-associated vestibular changes play a specific role in freezing of gait in Parkinson's disease; positive findings in this study may generative novel vestibular rehabilitative interventions in PD veterans with freezing of gait.